Structural basis of eukaryotic clamp loading

PROJECT SUMMARY
The maintenance of genome stability across generations is critical for human health and relies on the
efficient repair of spontaneous DNA lesions and the faithful duplication of all chromosomal DNA prior to cell
division. The highly conserved DNA sliding clamps PCNA and 9-1-1 are critical for these genome maintenance
mechanisms in eukaryotic cells by acting as mobile hubs for the assembly of the protein complexes mediating
the signaling and repair of DNA damage and conducting the faithful replication of the nuclear chromosomes.
The dynamic association of PCNA and 9-1-1 with chromosomal DNA is controlled by a set of four conserved
and related ATP-dependent clamp loader complexes that each perform non-redundant genome maintenance
functions in the cell. How eukaryotic clamp loaders target their client clamps to sites of DNA replication and
repair and load the clamps around DNA has been the subject of intense investigation for several decades.
Using advanced biochemical reconstitution approaches and cryogenic electron-microscopy (cryo-EM), we
have recently determined the first structures of active eukaryotic clamp loader:clamp:DNA complexes, which
revealed the molecular basis for the substrate specificities of the yeast RFC and Rad24-RFC complexes and
resulted in a significant revision of current clamp loading models. Building on this work, here we propose to
extend and advance the approaches established by us for the yeast RFC:PCNA and Rad24-RFC:9-1-1 clamp
loader systems to characterize the molecular mechanisms of the yeast and human orthologues of Ctf18-
RFC:PCNA, Elg1ATAD5-RFC:PCNA, and RAD17-RFC:9-1-1. The innovative approach leverages the expertise
of Dr. Remus’ laboratory in the biochemical reconstitution of eukaryotic DNA replication and the expertise of
Dr. Hite’s laboratory in the characterization of the conformational landscapes of protein complexes by cryo-EM.
The proposed studies will determine the mechanistic basis for the functional specialization of CTF18-RFC
(Aim 1), uncover the currently unknown mechanism of PCNA unloading by Elg1ATAD5-RFC:PCNA (Aim 2) and
visualize the spectrum of conformational states of the human RAD17-RFC:9-1-1 complex to reveal the
evolutionary conservation or divergence of the 9-1-1 checkpoint clamp loading mechanism (Aim 3).
Collectively, this work will provide novel mechanistic insight into fundamental genome maintenance pathways.

Public health relevance
PROJECT NARRATIVE DNA repair and DNA replication are of critical importance for the maintenance of the genetic information across generations. Mistakes made during these processes can lead to severe diseases, including cancer and developmental disorders. This project will investigate the molecular mechanism of a family of protein complexes, called clamp loaders, that are critical for DNA repair and replication in all eukaryotes.